Establishing Mechanisms of Benefit to Reinforce the Alzheimer's Care Experience AD/ADRD Roybal Center: EMBRACE

Program Summary/Abstract-Overall
With the advent of the National Alzheimer’s Project Act of 2011, funding and support to advance the
science of dementia care has increased substantially. There now exists significant research infrastructure to
support basic research on dementia care, intervention development and testing, and the integration of
dementia care interventions into healthcare systems. However, if the science of dementia care is to progress
towards the later stages of the NIH Stage Model, the development of scalable innovations that are more readily
disseminated and primed for implementation across settings (including homes and within community
organizations) is needed. One way to do so is to better understand why dementia care interventions work. The
primary objective of the Establishing Mechanisms of Benefit to Reinforce the Alzheimer’s Care
Experience AD/ADRD Roybal Center (EMBRACE) is to provide scientific infrastructure to support the
testing of mechanisms in tailored home and community dementia care intervention trials across
Stages 0-V of the NIH Stage Model. The Aims of EMBRACE are as follows: 1) Leverage the extensive
expertise of EMBRACE to attract and support early stage to expert Investigators to test mechanistically driven
dementia care interventions across the NIH Stage Model; 2) Advance the science of testing mechanisms of
tailored dementia care interventions in home and community settings; and 3) Conduct a robust evaluation of
EMBRACE to ensure appropriate progress of supported trials.
The science of dementia care interventions is at a crossroads. Despite significant infrastructure
investments on the part of the National Institute on Aging and other federal agencies, very few Stage I-III trials
have successfully progressed to subsequent effectiveness (Stage IV) and dissemination and implementation
(Stage V) testing in the NIH Stage Model. By relying on its national network of collaboration between the
University of Minnesota (Multiple Principal Investigator/MPI: Gaugler), the University of Wisconsin-Madison
(MPI Gilmore-Bykovskyi), and the NIA IMPACT Collaboratory (Behavioral Intervention Development Core Co-
Leads Hodgson and Gitlin well as six EMBRACE faculty), the proposed AD/ADRD Roybal Center will provide
unparalleled consultation and support throughout the lifecycle of intervention development and create
academic, scientific, and educational resources to guide the testing of mechanisms in dementia care
interventions across the NIH Stage Model.

Public health relevance
Project Narrative-Overall The primary objective of the Establishing Mechanisms of Benefit to Reinforce the Alzheimer’s Care Experience AD/ADRD Roybal Center (EMBRACE) is to provide scientific infrastructure to support the testing of mechanisms in tailored home and community dementia care intervention trials across Stages 0-V of the NIH Stage Model. The Aims of EMBRACE are as follows: 1) Leverage the extensive expertise of EMBRACE to attract and support early stage to expert Investigators to test mechanistically driven dementia care interventions across the NIH Stage Model; 2) Advance the science of testing mechanisms of tailored dementia care interventions in home and community settings; and 3) Conduct a robust evaluation of EMBRACE to ensure appropriate progress of supported trials.